Addiction potential, flavoring content, and substitutability of concept flavored cigarillos

PROJECT SUMMARY/ABSTRACT
This proposal is responsive to NIDA strategic plan initiatives focused on applying addiction science to improve
public health and policy. In April 2022, the Food and Drug Administration (FDA) announced proposed rulemaking to
ban all characterizing flavors other than tobacco (like Chery, Chocolate) from cigars.1 Cigarillos, the most widely sold
cigar product, are predominantly used by young adults (YAs, defined here as ages 18-24), as well as Black and Hispanic
individuals,2-5 and flavors are cited as a primary reason for their use.6-8 The emergence of “concept flavors” – vague
ambiguous flavor descriptors with no explicit flavor name – is a product characteristic used by tobacco companies to
evade local flavor bans9 and have been shown to appeal to YAs.10-12 Notably, of all other tobacco products, cigarillos
show the greatest increase in concept flavor sales in recent years, compared to sales of tobacco and other
characterizing flavors.6 Existing research, including our own, shows that explicit characterizing flavor descriptors on cigar
products are associated with greater perceptions of product appeal (e.g., subjective effects like taste, smell, and
enjoyment to smoke)13, 14 and use behavior14-16 relative to products labeled with tobacco flavor descriptors. Despite the
rapid increase in sales of concept flavored cigarillos6 and early evidence of the appeal of e-cigarettes with concept
descriptors17, the addiction potential of concept descriptors (e.g., subjective reinforcing effects, use behavior, motivation
to consume/purchase), especially among younger cigarillo users, remains unknown. These indices are important
indicators of the neurobiological systems that underlie addiction and motivate subsequent tobacco use.18, 19 Limited
research exists, but this is all done in adults, or via online experiments or cross-sectional designs20-23, indicating the
need for more studies. Only one laboratory study has investigated the impact of flavor on different indices of cigarillo
use and appeal,20 but it did not include concept flavors and recruited only cigar-naïve cigarette smokers. There is a
critical need to isolate the unique effects of concept descriptors on increased cigarillo use and appeal among
experienced YA cigarillo users. Without this information, regulatory actions will only target characterizing, but not concept
flavors, unintentionally shifting the cigar market to concept-flavored cigarillos. This would undermine the intended public
health benefits of a cigar flavor ban. To address this need, this multi-method study will determine the addiction potential
of concept flavored cigarillos in YA cigarillo users (N=300) by examining associations of cigarillo flavor type (concept,
characterizing, tobacco) and their flavoring additives to complementary measures of product appeal: subjective effects
(e.g., satisfaction, reward, taste), actual smoking behavior (e.g., number of puffs), and cigarillo purchasing, product
substitution, or quitting under different flavor ban scenarios via an Experimental Tobacco Marketplace (ETM).15, 24, 25
This study will contribute to the evidence-base that informs the implementation of the cigar flavor ban, can fortify FDA’s
claims in potential legal challenges to the ban, and inform the addiction potential of tobacco products with concept flavor
descriptors.

Public health relevance
PUBLIC HEALTH RELEVANCE This multi-method study will triangulate human laboratory, behavioral economic, and chemical analysis methods to examine the addiction potential of concept, characterizing, and tobacco flavored cigarillos in 300 young adult (YA) cigarillo users. The objective of this project is to provide valuable data to support the implementation of the Food and Drug Administration’s proposed ban on characterizing flavors in cigars. This proposal will answer important public health and policy relevant questions about the unique association of concept flavors on YAs appeal for cigarillos, the most popular cigar product, and the ways in which YAs could be influenced by a proposed regulatory action to ban flavors in cigars.